The roles of AP-1 pathway activation in NK cell development and exhaustion programming in AML

PROJECT SUMMARY/ABSTRACT
The 5-year overall survival rate for acute myeloid leukemia (AML) is less than 35%, making it the most fatal
leukemia in adults. Natural killer (NK) cells are a type of innate lymphoid cell (ILC) capable of recognizing and
killing malignant cells. We have previously demonstrated that NK cells are developmentally and functionally
impaired in AML. These impairments correlate to worse overall survival and clinical outcomes, highlighting the
importance of understanding the mechanisms by which AML alters NK cell development and function. To better
understand these defects, we assessed the transcriptional and epigenetic landscape of NK cells in AML and
discovered that mature NK cells from AML patients are globally hypomethylated when compared to normal
controls and have abnormal activation of activating protein-1 (AP-1). AP-1, which is a set of transcription factor
(TF) dimers primarily composed of Jun and Fos family proteins, has been shown to regulate ILC development
and homeostasis, chromatin accessibility, and immune cell exhaustion. The activity of AP-1 is regulated by
upstream mitogen activated protein kinases p38, JNK and ERK through transcription activation and post-
translational modifications. In this proposal, we will determine how the MEK/ERK signaling branch of the AP-1
signaling pathway contributes to NK cell defects in AML and whether development and function can be restored
through AP-1 pathway inhibition. We hypothesize that AP-1 signaling is a critical regulator of NK cell development
and function that becomes dysregulated in AML. These studies will first describe the mechanism(s) by which the
AP-1 pathway influences NK cell development in the setting of AML (Aim 1). We will use pharmacologic agents
as well as CRISPRcas9 editing to understand how aberrant AP-1 signaling skews human NK cell development.
We will also determine the functional consequences of aberrant AP-1 activation in mature NK cells (Aim 2).
Finally, we will assess the therapeutic efficacy of AP-1 pathway regulation in multiple in vivo models of AML (Aim
3). Results from these studies will further our mechanistic understanding of NK cell development in AML to better
inform therapeutic strategies.

Public health relevance
PROJECT NARRATIVE The studies outlined in this proposal aim to determine the mechanisms by which activating protein-1 (AP-1) influences natural killer (NK) cell development and function in the setting of acute myeloid leukemia (AML). Our comprehensive approach will allow for a deeper understanding of the developmental and functional consequences of AP-1 pathway signaling in NK cell precursors and mature NK cells in the setting of AML. The studies outlined in this proposal will reveal novel mechanisms that hinder NK cell development and function in AML.